Dissecting ventral pallidal plasticity in punishment-resistant opioid self-administration

PROJECT SUMMARY
Opioid use disorder (OUD) is an escalating public health concern, and has resulted in over 550,000 overdose
deaths between 1999 and 2020. Specifically, initial exposure to prescription opioids, such as oxycodone
(OXY), has contributed to an average of 13,850 deaths annually since 2018 (Centers for Disease Control).
While many individuals are able to use opioids as prescribed, a subset of individuals transition to compulsive
drug use, which is defined as continued drug intake despite negative consequences, and is a hallmark feature
of OUD. Similarly, most rodents will readily self-administer opioids, but will suppress their drug consumption
when drug intake is paired with punishment such as foot shock (punishment-sensitive); while ~20-25% will
persist in drug intake despite this punishment (punishment-resistant). Elucidating the neural mechanisms
underlying individual differences in punishment-resistant drug seeking will be critical for
understanding susceptibility to and treatment strategies for compulsive drug use. The ventral pallidum
(VP) has emerged as a critical brain area for encoding the relative value and motivation for rewards and
translating this motivation into reward seeking. The VP is a heterogeneous nucleus, with different populations
playing opposing roles in appetitive behavior. Specifically, we and others have established that glutamatergic
VP neurons (VPGlu) are crucial for constraining reward seeking in the face of aversive consequences, by
modulating activity of downstream brain areas involved in punishment learning, including the lateral habenula
(LHb) and rostromedial tegmental nucleus (RMTg). The objective of this proposal is to establish whether OXY-
SA decreases the excitability, in vivo activity and synaptic output of VPGlu neurons, and determine if these
adaptations are causally related to punishment-resistant OXY intake. Using complementary approaches of
electrophysiology, calcium detection with fiber photometry and chemogenetic manipulations, we will establish
whether OXY self-administration decreases excitability of VPGlu neurons, and whether this reduced activity is
necessary and sufficient for the emergence of punishment-resistant OXY intake (Aim 1). We will next use
electrophysiology and bidirectional optogenetic manipulations to determine whether reduced synaptic output
from VPGlu neurons to the LHb or RMTg is causally related to punishment-resistant OXY intake (Aim 2).
Finally, we will sequence actively translated mRNA from VPGlu neurons to determine gene networks that confer
risk and protection against punishment-resistant OXY intake (Aim 3). This will also allow us to identify and
validate potential pharmacological targets that could modulate VPGlu neuron activity in vivo as a therapeutic
strategy. Our long-term goal is to elucidate the neural circuit basis of punishment-resistant opioid intake, and
to leverage this understanding to develop neuromodulation therapies (such as deep brain stimulation with
targeted pharmacology) to treat persistent drug intake despite negative consequences in patients with OUD.

Public health relevance
PROJECT NARRATIVE Misuse of prescription opioids is a significant public health and economic burden; in 2020 in the United States, more than 9.9 million people reported prescription opioid misuse, and prescription opioids contributed to over 17,000 overdose deaths. A defining symptom of opioid use disorder is the inability to abstain from drug consumption in the face of aversive life consequences, which afflicts only a subset of individuals who take prescription opioids. Understanding the neural circuits that distinguish this subset of individuals who cannot inhibit drug consumption is necessary to predict which patients are at risk for developing opioid use disorder, and to prevent or reverse these neural circuit changes as a potential therapy.